Targeting Tumor-Associated Macrophages to Treat Lymphoma

T cell lymphomas (TCLs) are a highly heterogenous group of lymphoid malignancies originating from mature T
cells, representing approximately 12% of all non-Hodgkin lymphomas. TCL remains largely incurable with
existing therapies due to its extreme heterogeneity and rapid progression. Novel and more effective treatments
for TCL are urgently needed. In this context, we proposed an innovative strategy by inducing tumoricidal
activities of tumor-associated macrophages (TAMs) through targeting Ca2+/calmodulin-dependent protein
kinase II (CAMK2). Our prior research has underscored the pivotal role of CAMK2 in promoting TCL
development, with inhibiting CAMK2 proved to be effective in suppressing TCL progression. Recently, we have
unveiled a novel role of CAMK2 kinases in modulating macrophage-mediated immunosurveillance. Upon
CAMK2 inhibition, macrophages underwent repolarization and demonstrated enhanced phagocytic activity
against TCL cells. We further explore the molecular mechanisms through which CAMK2 regulates antitumoral
immunity of TAMs within the tumor microenvironment (TME) and determine the therapeutic potential of CAMK2
inhibition in facilitating the clearance of TCL cells. Our preliminary findings indicate that CAMK2 inhibition
reprogrammed human and mouse macrophages toward the M1 phenotype with enhanced phagocytic ability;
CAMK2 inhibition induced TFEB nuclear translocation, leading to upregulation of lysosomal genes in
macrophages; CAMK2 inhibition accelerated lysosomal biogenesis and acidification in macrophages,
facilitating lysosomal-mediated degradation; administration of a small molecule inhibitor targeting CAMK2
suppressed TCL tumor growth while depletion of macrophages reversed its antitumor effect. TFEB is a pivotal
regulator of lysosomal biogenesis, and its dephosphorylation prompts nuclear translocation, which
subsequently activates lysosomal biogenesis and acidification to augment the phagocytic ability of
macrophages. Therefore, we formed the following hypothesis: the inhibition of CAMK2 promotes the
phagocytic capacity of macrophages by inducing transcription factor EB (TFEB)-mediated lysosomal activity,
leading to enhanced elimination of TCL cells. To scrutinize the hypothesis, the proposed studies comprise
three Specific Aims: 1) define the effects of CAMK2 inhibition in reprogramming TAMs toward an anti-tumoral
phenotype; 2) dissect the molecular mechanisms underlying CAMK2 inhibition in TAM reprogramming; and 3)
determine the efficacy of CAMK2 inhibition in TCL growth with in vivo mouse models. Upon completion of this
project, we anticipate unveiling a novel mechanism by which CAMK2 regulates TAM phenotypes and anti-
tumor immunity via the CAMK2/TFEB axis. In addition, we expect to reveal the efficacy of targeting the
CAMK2/TFEB axis for TCL treatment using preclinical models.

Public health relevance
Because T cell lymphoma (TCL) remains largely incurable with existing therapies, novel and more effective treatments for TCL are urgently needed. In this proposal, we aimed to develop a strategy for TCL immunotherapy by inducing tumoricidal activities of tumor-associated macrophages (TAMs) through targeting CAMK2 kinase. By shedding light on a novel mechanism by which CAMK2 regulates TAM phenotypes and anti-tumor immunity via the CAMK2/TFEB axis, these studies may significantly impact the field of TCL research and lay a scientific foundation for developing future therapeutics to effectively treat TCL.